Chemical engineering of therapeutic RNAs for extrahepatic delivery

Summary
Small interfering RNAs (siRNAs) are informational drugs designed to treat genetically defined disorders and
promise to reshape our approach to human medicine. The clinical utility of siRNAs depends on functional
delivery to a tissue or cell type of interest, which is in turn defined by oligonucleotide chemistry. When a
chemical architecture—e.g., oligonucleotide modification pattern—that provides functional, non-toxic delivery to
a tissue is optimized, candidate drugs can be rapidly developed to treat diseases with the same tissue
involvement. Clinical utility of siRNA is proven in liver, where conjugation of a trivalent N-acetylgalactosamine
moiety enables efficient delivery to hepatocytes and therapeutic activity for a year after a single injection.
To expand siRNA utility to tissues beyond liver, our lab and others have explored chemical approaches altering
valency and lipophilicity, leading to two classes of siRNA chemical configurations that have opened a limited
number of other tissues to therapeutic intervention and are in clinical trials. To build on this success and fully
realize the potential of this technology, fundamental improvements are required in two areas: (i) siRNA potency
and durability in extrahepatic tissues, and (ii) targeted delivery of siRNA to extrahepatic tissues.
We have established the expertise in organic chemistry, combinatorial chemistry, oligonucleotide chemistry,
RISC biology, and siRNA pharmacology needed to solve these problems. In the last funding period, we (i)
discovered a novel biologically-compatible nucleic acid backbone—extended Nucleic Acid (exNA)—that, when
placed in defined positions of the siRNA backbone, enhances extrahepatic tissue exposure by more than an
order of magnitude; (ii) engineered novel siRNA chemical architectures that open lung, fat, muscle, placenta
and heart to functional gene modulation; (iii) defined novel classes of serum protein binding architectures to
dynamically modulate siRNA clearance; and (iv) advanced a “first in class” systemically-delivered lipophilic
siRNA to clinical trials.
Building on these recent advances, we propose three principal research directions that seek to (i) chemically
engineer siRNA scaffolds that enable complete stability, modulate endosomal release, and support sustained
siRNA efficacy in different tissues in vivo; (ii) engineer and discover novel ligands for targeted siRNA delivery
to extrahepatic tissues; and (iii) work with a network of expert collaborators to investigate the therapeutic
potential of novel chemical configurations in models of diseases with unmet medical needs.
Completing these studies will establish chemical architectures that enable functional extrahepatic delivery of
siRNAs and discover new compounds with potential to transform therapeutic approaches for many diseases.

Public health relevance
Project Narrative RNA-based therapeutics promise to revolutionize the treatment of inherited diseases. Yet, safe, effective, and target-tissue-specific delivery of the RNA that directs gene modulation is a critical hurdle in the clinical development of engineered RNA systems. We have established a framework for advanced and complete modification of therapeutic RNAs, thereby conferring in vivo stability and effective biodistribution properties, and have engineered targeted delivery to a range of tissues, expanding the clinical utility of this powerful therapeutic platform beyond the liver.